Administrative Core

PROJECT SUMMARY
The mission of the Administrative Core for the Chicago Chronic Condition Equity Network (C3EN) is to provide
leadership and strategic direction for all components of the Center, to cultivate and maintain strong alignment
with institutional goals and initiatives that ensure lasting support from University leaders and C3EN stakeholders,
and to support administrative processes necessary for efficient and effective Center operations. This Core will
provide overall oversight of the productivity, effectiveness, and relevance of Center activities; foster collaboration
and scientific opportunities related to the prevention and management of multiple chronic conditions among
stakeholder partners across the Chicago region; and leverage partnerships and institutional resources to attract
and retain diverse investigators new to the study of multiple chronic conditions. The Administrative Core will have
interaction with the Community Engagement Core, Investigator Development Core, as well as the R01 projects;
provide scientific and technical support for R01s as well as for future pilot studies; and oversee coordination of
data and resource sharing with the Coordinating Center. This Core will ensure that the bi-directional partnership
between the community and researchers is integrated throughout all aspects of the Center and support the
Community Engagement Core in creating a sustainable model for the co-development of ideas for research
interventions and dissemination throughout the Center network. The specific aims of the Administrative Core are
to 1) provide strategic direction, oversight and governance for all Center operations; 2) provide access to
scientific and technical expertise for research projects and pilot studies including informatics and statistics,
intersectoral health, and implementation science; 3) coordinate data sharing and integration across practice
networks and community-based organizations across the Chicago region; and 4) provide rigorous assessments
of productivity, eﬀectiveness, and appropriateness of Center activities, as well as scientiﬁc opportunities, and
areas of collaboration among Center partners. The Administrative Core will ensure that the C3EN functions with
high efficiency and achieves maximal impact in our city-wide, regional, and national efforts to eliminate chronic
disease-related health disparities and advance health equity.